Project 4

Project 4 ABSTRACT
Project 4 aims to develop a translational in vitro-to-in vivo testing strategy for evaluating the intertissue
and interindividual variability in responses to complex environmental exposures. This goal is
a critical part of the overall strategy of the Texas A&M University Superfund Research Center to
characterize and manage the human health risks associated with exposure to environmental
emergency-mobilized hazardous substances through the development of tools that can be used by
first responders, the impacted communities, and the government bodies involved in site
management and cleanup. In the past funding period, we not only developed a multi-tissue
“biological read-across” approach for complex environmental exposures in high-content/highthroughput
assays using human induced pluripotent stem cells (iPSC), but also demonstrated its
utility for quantitative estimation of hazard of complex environmental exposures through a number
of case studies that spanned community, national and international scales. These studies show
how new approach methodologies (NAMs) can be applied for assessment of risks from real-life
exposures. Our central hypothesis remains that a tiered risk-based strategy for safety evaluation
utilizing human organotypic in vitro cultures, combined with population-based reverse
toxicokinetics, can be used to accurately characterize the risks posed by combined exposures to
hazardous substances during environmental emergencies. First, we will develop a populationbased
human in vitro approach to characterize inter-tissue and inter-individual variability in
responses to complex environmental exposures. We will test the hypothesis that human populationbased
in vitro models can refine hazard predictions and characterize the molecular underpinnings
and extent of inter-tissue and inter-individual variability. Second, we will develop a high-throughput
reverse toxicokinetics (RTK) modeling approach for complex exposures to enable in vitro-to-in vivo
extrapolation (IVIVE) of environmental samples. Because IVIVE is critical for interpretation of in
vitro NAMs data in the context of human health, we hypothesize that novel exposomic analyses
and new organ-on-a-chip models can provide concentration- and combined exposure-dependent
RTK parameters needed for IVIVE, ultimately enabling more accurate predictions of effects in vivo.
Third, as part of Center’s Disaster Research Response (DR2) approach, we will demonstrate the
application of human multi-tissue and population-wide high-throughput in vitro models to disaster
research response. We will show how the “biological read-across” method developed in the past
funding period can be applied to DR2 by testing the hypothesis that in vitro toxicity data can be
used to quantitatively predict and characterize health hazard of environmental samples. We will
partner with all Projects to use their samples or collaborate on analytical, molecular and biomedical
engineering methods and techniques. We will work with all Cores for data analysis and
management, geospatial analysis, and translation of our research to the impacted communities
and other stakeholders. The data and methods from this project will be of critical importance in
responses to disasters.

Public health relevance
Project 4 NARRATIVE Project 4 will determine what cell-based human model systems best predict potential toxicity, including the extent of inter-individual and inter-tissue variability, in people who may be exposed to hazardous substances as a result of a disaster. We will also create a framework for testing mixtures of chemicals for toxicity in these cell-based systems and for how best to understand at what dose these mixtures may be harmful. The outcome of this project will be a set of experimental tools and computational models that can be used rapidly during/after natural or man-made disasters.